Neural mechanisms for decoding olfactory information in Drosophila

Project abstract
Neural encoding, the process by which the brain converts sensory stimuli into patterns of electrical
activity within neurons, is critical for sensation to guide action. Despite this importance, little is known about
how neural codes are actually used – or “decoded” – by downstream networks in the brain. This gap is due to
two basic challenges: (1) identifying the exact target neurons that decode the activity in a neural population,
and (2) recording from and manipulating those neurons in vivo during natural sensory stimulation.
Here, we propose to overcome these challenges by investigating how an olfactory neural code is
decoded by its downstream network in a tractable experimental system: the fruit fly, Drosophila. We use new
approaches to precisely control and measure the spatiotemporal dynamics of the population of central
projection neurons while recording from and manipulating their postsynaptic target neurons and networks. This
affords direct investigation into the biophysical mechanisms that enable downstream neurons to decode
specific information from the olfactory neural population code. In Aim 1, we will control temporal correlations of
activity in projection neurons to determine how these patterns are decoded by downstream neurons. In Aim 2,
we will manipulate ion channels, pumps, and synaptic inhibition in downstream neurons to identify mechanisms
of decoding. In Aim 3, we will test how these biophysical mechanisms of neural decoding sculpt behavioral
algorithms. Together, these studies will reveal basic mechanisms by which the brain decodes its own neural
code for olfaction.
The basic logic of neural coding is remarkably conserved between invertebrates and vertebrates.
These similarities suggest that discoveries made in the fruit fly will be relevant to the mechanisms of decoding
in other animals. A more thorough understanding of the principles of neural decoding within the brain has the
potential to transform the development of novel brain-machine interfaces that could improve the outcomes of
patients with brain injuries.

Public health relevance
Project narrative Despite its importance to normal brain function, neural decoding is much more poorly understood than the process of neural encoding. This proposal applies innovative methods to develop fundamental new knowledge about the circuit, cellular, and synaptic mechanisms of neural decoding. An improved understanding of how the brain processes its own sensory code could help guide the development of improved therapies for rehabilitation after brain injury.